Epigenetic regulation of natural killer cell memory

PROJECT SUMMARY / ABSTRACT
Understanding the fundamental processes that determine an optimal immune memory response has
been the bedrock of vaccine therapy and cell-based immunotherapy. Historically, therapeutic strategies have
focused on strengthening the adaptive immune arm, the primary agents that effectuate immunological memory.
More recently, research has expanded to include an innate immune arm that can retain a durable enhanced
capability after initial activation, a phenomenon more commonly known as trained immunity. Natural killer (NK)
cells have been pioneers in traversing the borders of innate and adaptive immunity, as best demonstrated in
studies on mouse and human cytomegalovirus infection, whereby NK cells can acquire long-lived memory in an
antigen-specific manner. At the same time, NK cells can acquire features of trained immunity, whereby activation
by proinflammatory cytokines can nonspecifically enhance longevity and functional potential that is maintained
weeks after primary exposure. Together, this malleability makes NK cells a promising and versatile tool for cell-
based immunotherapy. One of the fundamental mechanisms by which these NK cells and all immune memory
cells retain potential is via epigenetic reprogramming. This R01 proposal thus focuses on understanding and
dissecting out epigenetic features that establish an immune memory program, and how these programs
fundamentally differ between antigen-specific and trained immune memory. We study two related but non-
mutually exclusive readouts of epigenetic regulation: chromatin accessibility and DNA methylation. Based on our
previous work comparing the in vivo open chromatin landscapes of antigen-specific NK cells and CD8+ T cells,
we have identified AP-1 factor JunB as playing a role at least during early antigen-specific responses, and have
additional evidence that suggests it may also play a role in trained immunity. Based on performing similar
analyses that instead focus on the DNA methylome, we further explore the role of genome-wide active DNA
hypomethylation in establishing antigen-specific and trained NK cell memory responses. As a result, Aim 1
focuses on perturbing the open chromatin landscape via JunB-depletion, while Aim 2 disrupts the DNA
methylome via Tet2-depletion. By doing so, we will identify key candidate regulatory elements and genes that
link epigenetic activity to cellular and functional phenotypes, thereby providing a launchpad for therapeutic
strategies that co-opt NK cell memory traits to improve NK-cell based therapies.

Public health relevance
PROJECT NARRATIVE Immunological memory can come in two formats: (1) the well-studied classic antigen-specific responses of the adaptive immune arm, and (2) trained immunity, an emerging but still-developing concept of a nonspecific immune memory primarily mediated by innate cells. This proposal seeks to understand the epigenetic foundations that differentially or commonly define trained immunity and antigen-specific memory by studying a unique case study whereby natural killer (NK) cells, a part of the innate arm, can acquire both types of memory features. Defining the molecular mechanisms by which NK cells acquire heritable and durable effector and memory potential will unveil novel strategies to improve NK cell-based therapies.